Developing the Privately Owned Companion Dog as a Model for Alzheimers Disease

Alzheimer’s disease and other dementias represent an increasing burden on society, with an estimated
5.8 million Americans suffering from Alzheimer’s disease. A major barrier to progress in Alzheimer’s disease
research is a lack of suitable animal models that (1) show pathological hallmarks and clinical features similar to
those seen in patients with Alzheimer’s disease, and (2) have similar genetic and environmental heterogeneity
to people. The privately-owned companion dog uniquely captures both of these features.
The Dog Aging Project (DAP) is a consortium of investigators with the shared goal of understanding the
biological aging process, including age-related cognitive changes and dementia, in companion dogs through
large-scale longitudinal study and clinical evaluation of putative healthspan-promoting interventions. More than
50,000 companion dogs will ultimately be enrolled in the DAP Pack, for which detailed owner survey information
is collected annually, including the gold standard cognitive assessment questionnaire for diagnosis of canine
cognitive dysfunction (CCD). A high-resolution “Precision Group” of 1,000 dogs are being studied in much
greater depth, including full genome sequencing, veterinarian-reviewed electronic medical records (VEMRs),
and annual assessments including physical exam, clinical chemistry, blood epigenome, serum metabolome, and
fecal microbiome. We propose to synergistically leverage the infrastructure of the DAP to create an unparalleled
and one-of-a-kind resource for studying Alzheimer’s-like disease in the companion dog.
To accomplish this goal, we will (1) recruit 200 dogs with CCD into a “CCD Precision Group” which will
be studied at high resolution in parallel with the cognitively normal DAP Precision Group, including
assessments of serum abundance of AD markers such as Ab42, Tau, and hyperphosphorylated Tau, (2)
quantitatively assess proteomic and neuropathological hallmarks of Alzheimer’s-like disease in brains from 100
companion dogs who reach the end of their natural lives, and (3) create a large canine data and biospecimen
repository to support future studies of Alzheimer’s-like disease in companion dogs.
We anticipate that successful completion of this project will not only create a rich dataset on AD-like
disease in companion dogs, but will also spur numerous follow-on studies by other investigators. It is our hope
and expectation that these resources will have a major impact on Alzheimer’s disease research far into the
future.

Public health relevance
Alzheimer’s disease is a devastating and untreatable disorder that afflicts more than 50 million Americans directly and countless additional family members and caregivers. Progress toward developing treatments for Alzheimer’s disease are hampered by deficiencies in current animal models, particularly a lack of animal models (1) showing pathological hallmarks and clinical features similar to those seen in patients with Alzheimer’s disease, and (2) having similar genetic and environmental heterogeneity to people. The companion dog uniquely captures both of these features, and this proposal synergistically leverages the infrastructure and resources of the Dog Aging Project to establish the companion dog as a premier animal model for Alzheimer’s disease.